Cardiomyocyte-fibroblast signaling in atrial fibrillation

PROJECT SUMMARY / ABSTRACT
Atrial fibrillation (AF) contributes to at least 175,000 deaths per year in the US alone, and is a leading cause of
stroke. AF is expected to affect twelve million people in the U.S. by 2030. Atrial fibrosis is a key disease feature
linked to increased morbidity and mortality in patients with AF. Fibrosis (especially interstitial) creates a substrate
for atrial re-entrant arrhythmias and is associated with therapy resistance. Dysfunction of atrial cardiofibroblasts
(ACFs) that secrete excessive collagen into the extracellular matrix (ECM) is one of the important mechanisms
leading to fibrosis. Our recent studies revealed that calcitonin (CT), a paracrine signaling molecule released by
atrial cardiomyocytes (ACMs), suppresses collagen and other profibrotic ECM proteins production by ACFs.
The long-term goal of this project is to dissect the molecular and cellular basis of the CT signaling pathway
in relation to atrial fibrogenesis in AF in order to uncover new targets for future therapies in AF. The central
project hypothesis is that reduced CT production by ACMs, miR-31-dependent downregulation of CT-receptor
(CTR) expression, and activated BMP1 signaling downstream of the CTR promote atrial remodeling, fibrogenesis
and AF progression.
Two Specific Aims will be pursued: Aim 1) Determine whether miR-31-5p, via reduced CTR expression,
drives atrial profibrotic remodeling and AF development, and Aim 2) Define the role of BMP1 and MGP in the
CT/CTR signaling pathway in AF. This project is supported by a large amount of preliminary data that support
the central hypothesis. The proposed studies will be performed in freshly isolated and cultured ACFs obtained
from the right and left atria of patients with persistent AF (vs controls in sinus rhythm, or, in some cases, with
paroxysmal AF), and from various genetic mouse models of spontaneous AF. Numerous new reagents and
innovative multi-disciplinary approaches will be used to dissect the molecular basis of ACF phenotype changes
and profibrotic remodeling driven by changes in the CT-CTR-BMP1 signaling axis.
Impact: These studies are expected to underpin how suppressed CT/CTR signaling contributes to atrial
fibrosis and arrhythmia development, and to serve as a platform for the validation of novel treatment modalities
(up- and down-stream of CT/CTR axis) aimed at preventing atrial fibrogenesis and ameliorating AF development.

Public health relevance
PROJECT NARRATIVE The proposed work will elucidate the molecular basis of atrial fibrosis associated with the development of atrial fibrillation. The upstream and downstream mechanisms of the calcitonin-calcitonin receptor signaling pathway will be studied in cultured atrial fibroblasts from patients in atrial fibrillation or sinus rhythm controls, as well as various transgenic mouse lines. These studies may lead to the development of new therapeutic approaches for atrial fibrosis and atrial arrhythmias.